Exploring risk factors and predictors of endemic CKDu in agricultural regions of four Central America countries

PROJECT SUMMARY
Chronic kidney disease of unknown origin (CKDu) is highly prevalent in several tropical
regions, including Central America where it is most common among young adult males
working in sugarcane and other agricultural activities. It has taken a terrible toll on families
living in vulnerable conditions in rural areas. Despite efforts to study CKDu over the last two
decades, its causes are not fully understood and the disease continues to claim lives and
overwhelm healthcare systems. This project aims to identify risk factors and predictors for
estimated glomerular filtration rate (eGFR) decline among young individuals with and without
CKDu in rural endemic areas in four Central American countries: Costa Rica, Panama,
Nicaragua and Guatemala. We will comprehensively assess multiple risk factors related to
1) strenuous manual labor under heat stress with inadequate rest; 2) social determinants
(e.g., poverty, malnutrition, low birth weight); 3) vector-borne or zoonotic diseases; and 4)
exposure to known or novel toxins (e.g., heavy metals, agrochemicals, silica). We will also
collect bio-banked specimens to assess genetic risk factors and novel biomarkers of acute
kidney injury (AKI), as determined by the NIH Chronic Kidney Diseases of Uncertain Etiology
(CURE) consortium. As a Field Epidemiology Site, our primary study aims are: (a)
identification of cases and controls in endemic agricultural communities; (b) longitudinal
follow-up of both cases and controls; and (c) biopsies in a subset of individuals. Our
proposal takes advantage of the SALTRA network (Central American Program for Health,
Work and Environment). SALTRA has nearly 20 years of experience conducting research in
the region and has longstanding relationships with local communities, organizations and
governmental organizations, public health authorities and local nephrologists on the front
lines of fighting this disease.

Public health relevance
PROJECT NARRATIVE Chronic kidney disease of unknown origin (CKDu) has taken a terrible toll on young working families living in rural areas of Central America. This project aims to identify risk factors for CKDu and decline in kidney function in four Central American countries: Costa Rica, Panama, Nicaragua and Guatemala. We will assess work and environmental exposures, social determinants (e.g., vector-borne or zoonotic diseases; and exposure to toxins as possible causes. This work will be conducted though the SALTRA (Central American Program for Health, Work and Environment) network connecting locally-based universities, NGOs, governmental organizations, public health authorities and local healthcare workers.